Site-specific control of human gene regulation for therapeutically applicable mechanistic insights (R35GM143532)

Project Summary is not required for this submission.

Public health relevance
Project Narrative is not required for this submission.